Sex and Gender Enriched Neurology

SUMMARY/ABSTRACT
The overarching goal of this R25 Program is to leverage our rich institutional environment to iteratively develop
the materials and curricula necessary to train the first generation of neurologists how to systematically advance
both neurological care and research by prioritizing sex and gender considerations. From neurodevelopment to
neurodegeneration, sex and gender influence the risk and course of neurological diseases. It is essential that
neurologists provide care that is informed by a patient's reproductive goals and experiences, hormonal
transitions and treatments, and their gendered societal roles. However, we identified a significant national
training gap in these critical topics at all levels of neurology education and related key knowledge gaps in the
scientific literature that hinder the growth of this field. The SAGE (Sex- and Gender-Enriched) Neurology
Program at UCSF is designed to galvanize and integrate emerging clinical, educational and research efforts to
fill these important gaps through three key aims. These curricula and educational materials will initially target
UCSF neurology residency trainees (15 annually for a total class of 45) and UCSF medical students (165
annually) during core and/or selective neurology clerkships, as well as clinical fellows (20 annually). The
approach to curriculum development will be guided by the UCSF Center for Faculty Educators, using evidence-
based principles to optimize motivation, experiential learning, collaborative learning, and retention in adult mixed-
level learners. Our first objective (Aim 1) is to develop and implement a core best practices clinical curriculum
that accelerates the translation of SAGE principles into neurology clinical practice using both a core didactic for
all trainees, and a week-long selective for any interested trainee. Trainee participants' core clinical competency
and self-efficacy in providing neurological care informed by a patient's sex and gender will be systematically
evaluated. Our second objective (Aim 2) is to develop and implement a core research curriculum to train the next
generation of clinician-scientists to conduct and interpret neuroscience research by leveraging SAGE principles,
whether bench or bedside. We will develop and pilot a tool to apply a sex/gender lens to analyzing the design
and interpretation of basic, translational and clinical studies. We will evaluate learners' competency at using this
tool. Our third objective (Aim 3) is to promote active generation of new knowledge by pairing interested trainees
with a faculty mentor to develop and lead a quarterly interprofessional mentored inquiry workshops designed to
identify new areas of inquiry and create interprofessional research teams. Teams will then distil key points from
each session into publications and novel curricular materials that serve as evaluative benchmarks of success.
SAGE Neurology will transform the training of clinicians and clinician-scientists through the continued sustainable
long-term development, evaluation, and refinement of innovative, clinically-relevant curricular materials.
Curricular products will then be disseminated widely across UCSF departments, national academic neurology
programs, national neurological associations and the broader ORWH community.

Public health relevance
PROJECT NARRATIVE Our overarching goal is to leverage the rich institutional environment at UCSF to develop a core curriculum to train a first generation of neurologists (primary learners: residents; other learners: medical students and clinical fellows) who are competent in providing sex and gender informed neurological care, and in understanding how to design and interpret studies informed by sex and gender. Deep exploration opportunities for interest learners include planning a mentored inquiry workshop, and participating in outpatient clinical selectives. A roadmap will be developed to support dissemination of the curriculum to other institutions and societies.